Theory-based social media intervention for non-medical use of prescription opioids (NMUPO) in young adults

PROJECT SUMMARY/ABSTRACT
Non-medical use of prescription opioids (NMUPO) is a timely and significant public health issue in the United
States (US). Young adults are the key population vulnerable to NMUPO. Existing literature indicates that
NMUPO in young adults is influenced by a robust array of psychosocial factors. Tailored interventions guided
by a psychosocial theory, such as the information-motivation-behavioral skills (IMB) model, are urgently
needed for addressing NMUPO in young adults. One innovative approach is to reach out to and deliver
psychosocial interventions to young adults via social media technology, yet limited efforts have sought to
develop such interventions for NMUPO among young adults. Thus the scientific objective of this K01 is to
gather data via IMB-guided formative study regarding psychosocial influences on NMPUO and then to use
these findings to inform the development of a peer-led social media intervention designed to reduce NMUPO
among young adults. The career development objective of this K01 is to obtain intensive mentored training
essential to improving the theoretical and practical expertise needed to develop innovative and implementable
peer-led psychosocial interventions for NMUPO in high-risk populations. The training will be supported by the
rigorous and highly productive research environment at the University of South Carolina and by a mentor team
with expertise in addiction treatment, health psychology, peer support group, formative assessment, social
media and psychosocial intervention design, mixed methodology, ecological momentary assessment, as well as
intervention development, implementation, and evaluation. Training progression is linked to three specific
research aims. In Aim 1, we conduct formative research, guided by the IMB model, to explore psychosocial
contents associated with NMUPO in young adults. We then use the findings from Aim 1 to develop a peer-led
social media intervention to reduce NMUPO among young adults (Aim 2) by integrating promising
psychotherapy principles and incorporating with peer leaders who are well-trained for recovery coaching. In
Aim 3, we conduct a pretesting of the feasibility, acceptability, usability, and preliminary efficacy on NMUPO
reduction and psychosocial changes of the theory-based social media intervention with a 12-week pilot
randomized controlled trial among 70 NMUPO engaging young adults (35 for intervention and 35 for control)
via pre-test, 12-week ecological momentary assessment (during the intervention), and post-tests (12-month
follow-ups). This project will contribute to future largescale and fully-powered psychosocial interventions for
NMUPO among young adults or other high-risk populations using innovative technology that can address
challenges in traditional substance use interventions.

Public health relevance
PROJECT NARRATIVE Non-medical of prescription opioids (NMUPO) in young adults is particularly concerning and is robustly influenced by psychosocial factors. Given the advantages of flexibility, wide coverage, and real-time responses/assessment, social media can be a promising and innovative approach to deliver psychosocial intervention to young adults but yet few theory-based social media interventions are available for NMUPO in this at-risk population. The proposed plan for research and career development addresses the critical gaps by theoretically exploring psychosocial contents associated with NMUPO among young adults via the formative assessment and using these findings to develop and pilot-test the feasibility and preliminary efficacy of a theory-based and peer-led social media intervention to reduce NMUPO and address psychosocial factors among young adults.